Implementing patient-centered strategies to optimize hospitalization decisions for emergency department patients with acute heart failure

Abstract/Project Summary
Candidate: Austin Kilaru, MD MSHP, is an emergency physician and health services researcher who is
committed to improving outcomes for patients with acute cardiovascular illness through the implementation of
evidence-based care. To achieve his career goal of becoming an independent investigator, he seeks mentored
research training to strengthen skills in qualitative methods, causal inference, and implementation science.
Research Context: Each year, there are 1.4 million visits to US emergency departments (EDs) for acute heart
failure (AHF). Stable patients can be discharged from the ED after initial evaluation and treatment, but nearly
90% of patients are hospitalized. Evidence-based risk scores have been developed to inform hospitalization
decisions for AHF, given that patients may prefer to recover at home and the costs and outcomes associated
with hospitalization. However, AHF risk scores are not widely used. Moreover, they do not consider additional
factors that may be important to hospitalization decisions, including access to care, capacity for self-care, and
health-related social needs. Scalable approaches, like clinical decision support tools, are needed to promote
AHF risk stratification and supplement risk scores with additional factors that matter to patients and clinicians.
Specific Aims: 1) Identify factors that influence AHF hospitalization decisions for ED patients and physicians;
2) Compare outcomes for low-risk AHF patients who are hospitalized to those discharged from the ED; 3) Pilot
and evaluate implementation of a clinical decision support tool for AHF hospitalization.
Research Plan: To accomplish these aims, Dr. Kilaru will first conduct qualitative interviews with low-risk AHF
patients who were either hospitalized or discharged from Penn Medicine EDs. He will also conduct interviews
with ED physicians to examine decision-making factors. Then, he will use electronic health record data for a
retrospective cohort study to determine the association of hospitalization with outcomes among low-risk AHF
patients, seeking to further test AHF risk score effectiveness and inform implementation strategies. Finally, he
will design and implement a clinical decision support tool, based in the electronic health record (EHR), among
ED physicians at Penn Medicine, evaluating outcomes including acceptability, adoption, and feasibility.
Career Development Plan: Working closely with his mentorship team, Dr. Kilaru will pursue didactics,
seminars, and individualized instruction to complete his training goals, which are to 1) expand skills in
qualitative methods to focus on patients and clinicians 2) apply causal inference techniques to analyze EHR
data, and 3) gain implementation science expertise to design and test innovations in care delivery.
Environment: The University of Pennsylvania and Penn Medicine offer an ideal environment to pursue this
training and research. Dr. Kilaru will succeed because of the support of an experienced and dedicated
mentorship team, outstanding research infrastructure, and extensive resources for professional development.

Public health relevance
Project Narrative Of the 1.4 million annual visits to US emergency departments (EDs) for acute heart failure (AHF), nearly 90% lead to hospitalization, although many stable patients can be discharged from the ED and continue to recover at home. This proposal seeks to develop novel, patient-centered strategies to optimize hospitalization decisions for AHF, building upon extensive work to derive evidence-based clinical risk scores. My aims are to examine patient and clinician perspectives to better understand reasons for hospitalization, compare outcomes between low-risk patients who are hospitalized to those who are discharged from the ED, and pilot the implementation of a clinical decision support tool that encourages ED clinicians to perform comprehensive risk stratification for patients with AHF.